Dissecting the biology and consequence of circulating glioma cells

PROJECT SUMMARY/ABSTRACT
Glioblastoma multiforme (GB) or grade IV glioma, is one of the most lethal human malignancies
and the most common malignant primary brain tumor in adults, with a current median survival of only
14 months. Despite aggressive standard-of-care treatments including surgical resection, radiation, and
chemotherapy, local recurrence of GB is essentially universal, and recurrent tumors are highly resistant
to conventional cytotoxic treatments. New treatment strategies based on an improved understanding
of recurrence mechanisms are desperately needed to improve overall survival for these patients. It has
been highly suggested that treatment-resistant glioma cells, particularly glioma stem cells (GSCs), i.e.,
tumor-initiating cells or tumor-propagating cells, contribute to GB recurrence via translocation from
parenchymal GSC niches. We propose an intriguing new mechanism whereby glioma cells in
circulation can similarly contribute to tumor development/regrowth. Utilizing human specimen and
orthotopic, genetic mouse tumor models our preliminary data demonstrate that these circulating glioma
cells (CGCs) acquire a cancer stem cell-like phenotype: activated in stemness, resistant to genotoxic
treatments, and more importantly, capable of homing to a primary tumor site to repopulate locally and
contribute to new tumor formation. This suggests a previously unidentified role of CGCs in tumor
micrometastases and local relapse in GB and possibly other solid tumors. We are uniquely positioned
(as the first group to report on the identification of circulating glioma cells - CGCs) to extend our
investigations to: i) decipher the key molecular features underlying CGC development and the potential
contribution of CGCs to tumor bed recurrences, ii) discover novel therapeutic interventions against
CGCs to overcome the universal local recurrence patterns seen in GB. Our proposal seeks to
accomplish these translationally-relevant objectives through an innovative set of complementary
strategies. Based on our preliminary results and expertise of the assembled team, we propose to test
the hypothesis that CGCs recapitulate the features of CSCs, contribute to primary tumor reseeding and
that molecular targeting of CGCs provide a novel strategy to overcome GB therapy resistance. To test
this hypothesis, we propose the following specific aims: AIM 1. Define the potential stem cell features
and transcriptional landscape of CGC by performing single cell RNA-seq. AIM 2. Determine the WNT-
dependent mechanisms for CGC-mediated GB tumorigenesis. AIM 3. Test the therapeutic efficacy of
WNT inhibition in GB tumorigenesis and therapy resistance. By accomplishing these aims via our
combined interdisciplinary expertise, infrastructure, and discovery of a novel GB recurrence paradigm,
we seek to build the foundation for an improved therapeutic approach for GB.

Public health relevance
PROJECT NARRATIVE Glioblastoma multiforme (GB) is the most common and deadly form of adult primary brain cancer with a current median survival of just over one year. This research focuses on the study and evaluation of the potential pathologic role of circulating glioma cells (CGCs) and the characteristics and signaling mechanism(s) which generate and sustain this subpopulation. Results of these studies will ultimately benefit public health by potentially improving our understanding of glioma tumor biology, mechanisms of recurrence, and evaluating novel therapeutic approaches against these brain tumors and cancers in general.